Linking Human TB Genetic Susceptibility Loci to Granuloma Biology

Abstract
Mycobacterium tuberculosis kills approximately 1.4 million people annually. People
exposed to similar initial doses may have very different outcomes, ranging from clearance
to active disease to subclinical or latent infection. A central structure of tuberculosis, the
granuloma represents a key interface between pathogen and host, and its dynamics
contribute to disease outcome. Granuloma macrophages induce expression of an unusual
epithelioid program that dictates granuloma structure and infection trajectory. Due to a
lack of genetically tractable animal models that fully reproduce key aspects of granuloma
biology – namely, epithelioid transformation and necrosis – many aspects of granuloma
formation have not been probed. Genome-wide association studies in humans have
identified several potential TB susceptibility loci, but the mechanisms by which these
genes act, particularly within the granuloma, are not well understood. Here we will link
established human genetic susceptibility loci to the biology of mycobacterial granulomas.
We will use murine, zebrafish, and explant models of bona fide mycobacterial granulomas
to directly probe granuloma structure, epithelioid state, immune and drug access and
granuloma dynamics. Using single cell transcriptional profiling and host and bacterial
mutants, we have defined a repertoire of diverse cell types and transcriptional states that
contribute to the physiological properties of the mycobacterial granuloma. We will define
how alteration of host immune pathways identified in genome-wide human genetic studies
alter granuloma biology through murine and zebrafish models that recapitulate key
properties of human granulomas, including caseation necrosis and epithelioid
transformation. We will validate these findings in human TB granuloma specimens. Finally,
we will use comprehensive TnSeq profiling using saturating Mtb transposon libraries to
define the interplay between bacteria and host within the context of the tuberculous
granuloma. Overall, these approaches will lead to a fuller understanding of granuloma
biology as well as new opportunities for therapeutic interventions.

Public health relevance
Project Narrative This project will investigate how genetic pathways identified in humans influence the central structure of tuberculosis, the mycobacterial granuloma. We will investigate how host genetic variation determines the architecture and dynamics of the granuloma, and test functionally how infecting Mycobacterium tuberculosis responds within the constraints of this structure to survive and replicate. Understanding granuloma biology more fully may provide new therapeutic opportunities to combat tuberculosis.